2025 Nitric Oxide Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
This proposal seeks partial support for the 2025 Gordon Research Conference on "Nitric Oxide and Sulfide in
Redox Signaling and Medicine" and the associated Seminar entitled "The chemistry and medicine of NO and
sulfur species" to be held on February 9-14, 2025, at the Four Points Sheraton/Holiday Inn Express in Ventura,
California. The broad and long-term goal of this conference is to bring together the world’s leading researchers
in the fields of NO and sulfide, and to foster cross-disciplinary discussions and collaborations. The event will be
chaired by Dr. Miriam M. Cortese-Krott from the University of Düsseldorf (Germany) and with the contribution
of Vice Chairs Dr. Amrita Ahluwalia and Dr. Adam Straub. This conference will serve as a nexus for basic
chemistry, cellular redox signaling, and emerging areas such as single-cell analysis, Redox Omics, and the
application of deep learning in Redox Medicine. This will facilitate the exchange of unpublished findings,
discussion of novel opportunities, and the establishment of collaborations, enhancing our understanding and
application of NO and sulfur species in health and disease. The specific aims include (1) showcasing cutting-
edge advancements in the NO/Sulfide/Redox Signaling field (single-cell analysis, FRET technology, cell-cell
and interorgan communication, mechanobiology, and metabolism); (2) exploring the pathophysiology of the
NO/sulfide interactome; (3) identifying environmental/nutritional effectors; (4) identifying new mechanisms and
therapeutic targets; (5) promoting diversity; and (6) inclusion and education of trainees within the scientific
community. The GRC program will be structured into nine sessions that comprehensively cover the field, with
sessions on the chemistry and pharmacology of NO/sulfur species, non-canonical signaling, redox targets,
mechanotransduction, translation, and clinical application. Basic, translational, and clinical research will be
highlighted, with a major emphasis on Redox Medicine and the long-term goal of improving human health.
Active participation by graduate students and postdoctoral fellows in the GRC will be facilitated and strongly
encouraged by Chairs and Discussion Leaders, with “elevator pitch” presentations and a formal poster session
in the afternoon. The significance of this application lies in the much-needed forum provided by the GRC and
GRS to bring together and synergize the members of an international research community working on NO and
Sulfide. The GRS, chaired by Drs. Sophia Heuser and Luke Dunaway is specifically designed for trainees,
allowing them to present their research and interact in a relaxing and supportive environment that promotes
their education as distinguished future members of the field. The Chairs will make every effort to promote
gender parity and include minorities and people with disabilities. The meeting is structured to support the
mission of advancing NO research, with a budget that reflects the goal of increasing participation among
trainees by facilitating their attendance at events. This approach is expected to maximize opportunities for
interaction and professional development within the community.

Public health relevance
PROJECT NARRATIVE The 2025 Gordon Research Conference (GRC) on "Nitric Oxide and Sulfide in Redox Signaling and Medicine" focuses on the intricate biological chemistry of nitric oxide and sulfide and their therapeutic challenges and benefits, particularly in cardiovascular health. The discussions will cover the basic chemistry of NO and Sulfide, their interactions with other molecules and targets, and their significant potential in treating diseases such as lung, heart and blood disorders, showcasing the ongoing evolution of understanding and applying NO and sulfide in medical science.